The Proactive and Reactive Neuromechanics of Instability in Aging and Dementia with Lewy Bodies

PROJECT SUMMARY
Our rapidly aging population remains at an exceptionally high risk of debilitating falls. This is especially concerning given
the compounding effects of dementia. In particular, Dementia with Lewy Bodies (DLB) is uniquely associated with an
increased prevalence of falls. Developing an improved mechanistic framework to understand balance impairment due to
age aging and DLB to mitigate falls risk is at the heart of this proposal. The neuromechanics of standing and walking balance
control, and thus the origins of balance impairment due to aging and DLB, are incredibly complex. Proactive responses
precede the onset of a balance challenge via feedforward control to prepare the body to accommodate instability.
Conversely, reactive responses follow the onset of a balance challenge and are compensatory, requiring rapid corrections to
mitigate instability. The overarching scientific premise of this fellowship proposal is that aging negatively affects reactive
balance responses, while the compounding effects of age and cognitive decline negatively affect proactive balance responses
in people with DLB, thus increasing vulnerability to real-world balance challenges that can precipitate falls. This cross-
sectional fellowship study will enroll 25 young adults, 25 older adults with clinically probable DLB, and 25 age- and sex-
matched older adults. I will strategically combine quantitative motion capture, electromyography, dynamic in vivo
ultrasound imaging, and wearable sensors with an innovative suite of standing and walking perturbation paradigms designed
to emulate real-world balance challenges. Aim 1 will determine the effects of age and LBD on whole-body vulnerability to
anticipated and unanticipated balance challenges during standing and walking. Aim 2 will characterize the local muscle
neuromechanical determinants of reactive and proactive balance responses across these cohorts. Finally, with community-
based translation as the ultimate goal of my scientific and professional development, Aim 3 will quantify the viability of
wearable sensors to monitor and detect between-group differences in vulnerability to perturbations. This study will be the
first to objectively quantify between-group differences in multi-scale characteristics of proactive and reactive balance
responses using laboratory-based and wearable-sensor based outcomes designed to move my discoveries from the laboratory
to the clinic and the community. This area of mechanistic and hypothesis-driven research has been severely understudied,
but has significant and immediate potential to inform novel advances in diagnostics, rehabilitation, mobile monitoring, and
wearable assistive technologies to mitigate falls.

Public health relevance
RELEVANCE TO PUBLIC HEALTH This work will establish the impact of aging and Dementia with Lewy Bodies on standing and walking stability through a combination of sophisticated motion capture, electromyography, in vivo ultrasound imaging, and wearable sensors. The proposed research is designed to move my discoveries from the laboratory to the clinic and the community. With clinical translation as the ultimate goal, this work will pave the way for prescription of personalized interventions, wearable sensor monitoring to mitigate falls, and development of assistive devices with onboard monitoring of muscle neuromechanics to deliver assistance in the face of a balance challenge.